Improving Serious Illness Care for Underserved Populations: Patient and Caregiver Experience with Tele-Palliative Care

Project Abstract
There is significant unmet need among seriously ill patients and gaps in quality of communication with health care providers. For patients suffering from serious illness, palliative care provides expert pain and symptom management and planning for end-of-life care. In particular, palliative care offered via telehealth may improve access to outpatient palliative care services, which are predominantly offered in large academic medical centers in metropolitan areas. Despite an increase in telehealth for outpatient palliative care, little is known about the perspectives of patients on modality of palliative care and how communication may be impacted by a virtual mode of delivery. In this prospective cohort study, we will enroll a cohort of adult patients referred to outpatient palliative care to compare care experiences of in-person versus tele-palliative care visits and understand the nuances around their needs and preferences for modality of care. Using mixed methods we will 1) evaluate both patient- and caregiver-reported experience with in-person and tele- palliative care over time using patient and caregiver-specific surveys and in-depth interviews with patients and caregivers; 2) compare communication quality and use of recommended communication processes between in- person and tele-palliative care using an analysis of recorded in-person and telehealth visits; and 3) examine perspectives of in-person visits versus tele-palliative care including perceived barriers and facilitators to both modes of delivery using qualitative interviews with palliative care providers. The proposed research will improve understanding of the experiences seriously ill patients and their family caregivers to address issues around mode of delivery of palliative care. Findings will provide a roadmap for health systems to improve patient-provider communication and identify strategies to improve experience and overall quality of palliative care delivered both in person and via telehealth.

Public health relevance
Despite an increase in telehealth for outpatient palliative care, little is known about the perspectives on modality of outpatient palliative care patients and how communication may be impacted by a virtual mode of delivery. This prospective cohort study uses a mixed-methods approach to examine and compare care experiences for in-person versus tele-palliative care provided to patients and their caregivers and to evaluate palliative care provider perspectives on the perceived effectiveness of tele-palliative care. Findings will provide a roadmap for health systems to improve patient-provider communication and identify strategies to improve experience and overall quality of palliative care delivered both in person and via telehealth to seriously ill patients and their family caregivers.